Neural Circuits that Process Visual Information

PROJECT SUMMARY
Before visual signals from the eye reach the cortex, they are processed by two powerful inhibitory networks in
the thalamus. First, local interneurons within the dorsal lateral geniculate nucleus (dLGN) provide feedforward
inhibition to relay cells and each other. Second, the thalamic reticular nucleus (TRN) receives input from relay
cells and inhibits them in return. These basic circuit elements are repeated across primary thalamic nuclei in
most mammals, including humans. Characterizing inhibitory networks in the dLGN is, thus, key to
understanding the early visual pathway as a whole and the thalamus in particular. Further, understanding how
healthy brains work provides a basis to help diagnose disorders and restore function in disease. Here we explore
intrinsic circuits in the thalamus by recording from interneurons themselves and the inhibition they supply to
relay cells during vision, using an interdisciplinary approach that combines different experimental techniques
with custom computational methods. The proposal is divided into three aims. Aim 1 asks how visual responses
in the TRN are derived and how this structure influences dLGN. Our past work showed that receptive fields in
the cat visual TRN are selective for specific elements of the visual scene and operate over local spatial scales;
these results are consistent with roles in feature processing and spatial attention. Recent studies of attention in
mouse, and our own preliminary results, suggest that the TRN may play the same roles in rodents as in carnivores
and primates. Thus, we will continue our studies of TRN in mouse, a tractable preparation in which reticular
cells can be located and manipulated optogenetically. Aim 2 focuses on local interneurons in the dLGN. We
will map their receptive fields and explore their tuning for stimulus attributes such as direction of motion,
orientation and size in order to delineate the inhibitory mechanisms that contribute to feature selectivity in relay
cells. Subsequently, we will use optogenetic tools to suppress interneurons and ask how the loss of their input
impairs stimulus selectivity in relay cells. Last, Aim 3 uses comparative approaches to highlight structural and
functional strategies that brains use to interpret the environment. For example, push-pull excitation and
inhibition are present in retinal ganglion cells from mouse to monkey and in relay cells of every species we test:
this synaptic arrangement seems key to form vision. Yet, our preliminary results suggest that the visual response
properties of the interneurons that supply inhibition to relay cells differ, not only between cat and mouse, but
even between animals in the same taxonomic order, cats and ferrets. We will use simple computational models
to understand how different inhibitory circuits can achieve common functional outcomes. Our belief is that
comparative approaches are crucial for relating research done in one species to another and, ultimately, for
understanding human visual processing.

Public health relevance
PROJECT NARRATIVE Synapses made by inhibitory neurons dominate the intrinsic circuitry of the visual thalamus and influence all signals traveling from retina to cortex. Here we use a highly interdisciplinary approach that combines diverse experimental techniques with theory to ask how inhibitory circuits in thalamus enhance selectivity for stimulus features and contribute to visual processing. Our premise is that without understanding how basic circuits operate in the healthy animal, one cannot appreciate how these circuits are altered in disease, such as disorders that compromise vision (amblyopia, strabismus) or cognition (schizophrenia, autism).